Discovery of apoE4 modulators for Alzheimer’s disease therapy

PROJECT SUMMARY
Alzheimer's disease (AD) is the most common form of dementia accompanied by detrimental cognitive
deficits and pathological accumulation of amyloid-β (Aβ) plaques and tau-containing neurofibrillary tangles. The
majority of AD cases occur late in life, and it usually develops after 65 years of age. The strongest genetic risk
factor for late-onset AD (LOAD) is apolipoprotein E (APOE) genotype, with the ε4 allele increasing AD risk and
the ε2 allele being protective compared with the common ε3 allele. Increasing evidence indicates that down-
regulation of apoE4 protein level and/or inhibition of apoE4 aggregation not only alleviate amyloid pathology but
also protect against tau-mediated neurodegeneration. In our preliminary studies, we have developed an apoE4
reporter assay with a split luciferase protein-fragment complementation, enabling us to not only monitor apoE4
protein level but also measure apoE4 self-oligomerization/aggregation by luciferase bioluminescent signals in a
high-throughput screening format. Under the support of the Mayo-SBP (Sanford Burnham Prebys) Drug
Discovery Collaboration Program, we performed a pilot screen of ~17,000 small molecule compounds with
satisfactory performance, and discovered a novel apoE4 modulator that down-regulates apoE4 protein level and
inhibits tau phosphorylation in induced pluripotent stem cells (iPSCs)-derived cerebral organoids from AD patient
carrying APOE4, demonstrating that our HTS assay is robust and capable of identifying novel apoE4 modulators.
Herein, we proposed a collaborative effort to identify apoE4 modulators that down-regulate apoE4 protein level
and/or suppress apoE4 aggregation for AD therapy. Aim 1 will complete the apoE4 reporter high-throughput
screen on a large chemical library to identify potent and specific apoE4 modulators for suppressing apoE4 level
and/or aggregation. Aim 2 will examine the potency, modes of actin (MOA), and therapeutic effects of apoE4
modulators using biochemical and cell-based assays and human iPSC-derived cellular models. Aim 3 will
perform SAR-by-catalog and limited chemistry on lead compounds to improve their potency and efficacy and
determine the therapeutic efficacy of the most promising candidate compounds in 3-D cerebral organoid models
such that our findings may have relevance in a humanized setting. Moreover, the “drug-like” and
pharmacokinetics properties and brain penetration will be characterized and benchmarked to position them for
future in vivo preclinical animal studies. The identified apoE4 modulators will be promising drug leads in novel
therapeutic strategies for AD.

Public health relevance
PROJECT NARRATIVE The ε4 allele of the apolipoprotein E (APOE) gene is the strongest genetic risk factor for Alzheimer disease. ApoE4 exacerbates not only amyloid pathology but also tau-mediated neurodegeneration. Our proposal seeks to identify small molecule apoE4 inhibitors, thereby reducing apoE4-related pathogenic effects for AD therapy.